Center for Coordination of Analysis, Science, Enhancement, and Logistics (CASEL) in Tobacco Regulatory Science - Analysis and Rapid Response Core

PROJECT ABSTRACT – ANALYSIS AND RAPID RESPONSE CORE
The principal goal of the Analysis and Rapid Response Core (ARRC) is to serve as a central scientific hub to
foster rapid, responsive, and rigorous collaborative tobacco regulatory science (TRS) and provide
methodological and analytic expertise to expedite TRS research pertinent to the Center for Tobacco Product's
(CTP's) regulatory mission. The ARRC will promote the use of common measures, protocols, and terminology
and provide support for data harmonization and sharing. CASEL's central coordinating role in TRS research
provides us with an informed vantage, “big picture” view of the TRS research portfolio and its investigators,
facilitating the ability to identify opportunities for coordination, collaboration, and synthesis of research among
the Tobacco Centers of Regulatory Science (TCORS) and other CTP-funded grantees, as well as surveillance
projects such as the Center for Rapid Surveillance of Tobacco (CRST) and the Population Assessment of
Tobacco and Health (PATH) Study. The result of these efforts will be collaborative, coordinated, and
synergistic TRS research that is robust and optimizes impact. Under the leadership of Dr. Cassandra Stanton
(proposed as ARRC Lead), We will build on the work of CECTR and CASEL 1.0 to use the tools and
processes developed to keep pace with the changing landscape, and we will work with our Federal partners to
identify and respond to research priorities and needs. We will continue to provide rapid response to analytic
needs through training, resource development, and consultation to advance methodological rigor to address
time-sensitive and critical research questions. We are also well-positioned to deliver efficient management of
the new Opportunity Fund (OF) program to award funds to innovative research projects.